EFFICACY OF SR57746A IN PATIENTS WITH AMYOTROPHIC LATERAL SCLEROSIS

This study asseses the efficacy, safety, and tolerability study of SR 57746A in patients with amyotrophic lateral sclerosis (ALS) receiving standard therapy (Riluzole).